Native Center for Alcohol Research and Education

OVERVIEW ABSTRACT
Dr. George Koob, the Director of the National Institute on Alcohol Abuse and Alcoholism, recently called for
programs that identify and promote effective preventive interventions tailored to Native people. The Native
Center for Alcohol Research and Education (NCARE) at Washington State University, with our partners at the
University of Colorado Denver and the University of Washington, offers coordinated efforts to mitigate and
ultimately eliminate the alcohol-related devastation experienced by American Indian and Alaska Native (AI/AN)
peoples through theory-based application of strategic and sustainable interventions. Achieving this goal will
reduce the profound alcohol-related health disparities experienced by this underserved population. Our research
agenda articulates a practical model of Native health that is grounded in theory and the daily lives of Native
people. Our Research Projects and Pilot Projects will reach Native infants, youth, and adults in urban, rural, and
frontier communities. Although our perspective is broad, our pragmatic grounding in the social, economic, and
healthcare systems experienced by Native communities will be understandable and relevant to many audiences,
including tribal communities, researchers, and clinicians. This grounding also increases the likelihood that our
findings will translate into public health benefits. Our efforts will foreground prevention and intervention while
contributing empirical evidence to the national conversation on healthcare costs. Collectively, this work has the
potential to improve the quality of life for AI/AN with alcohol use disorders, as well as for their families and
communities. NCARE proposes these activities: 1) Research Project 1: Compare the effectiveness a culturally
adapted intervention against usual care for reducing risky drinking and increasing contraception use to prevent
alcohol-exposed pregnancy and fetal alcohol spectrum disorders among Cheyenne River Sioux women in South
Dakota; 2) Research Project 2: Compare the effectiveness of a talking circle intervention against usual care for
reducing harmful behaviors and improving quality of life and healthcare use in urban Native clinic patients with
alcohol problems in Seattle, Washington; and 3) Research Project 3: Test the effectiveness of motivational
interviewing plus patient navigation for increasing enrollment in alcohol treatment programs and preventing re-
admission to detoxification treatment for patients discharged from the Fairbanks Native Association detoxification
unit in Fairbanks, Alaska. For all 3 Projects, we will conduct an economic evaluation of the interventions. These
3 Research Projects will be supported by the Administrative, Information Dissemination, Research Methods, and
Pilot Project Cores. Notably, our research team includes 11 Native professionals participating in diverse roles,
including Co-Leaders on all Cores and Research Projects. This unique connection between our investigators
and our study population imbues our work with a special dynamic, supporting efforts to move Native alcohol
research beyond a current, largely descriptive state into meaningful action.

Public health relevance
OVERVIEW NARRATIVE To reduce alcohol-related health disparities, the proposed Center aims to ameliorate alcohol use disorders and their behavioral and physical health consequences in American Indians and Alaska Natives. Our transdisciplinary research will examine multiple influences on alcohol-related disorders at multiple levels with multiple strategies across the lifespan.